Improving Video Visit Adoption by Surgeons

PROJECT SUMMARY/ABSTRACT
Dr. Chad Ellimoottil is a surgical specialist whose long-term career goal is to improve patient outcomes through
fostering the adoption of video visits. Current research demonstrates that surgical video visits can 1) reduce
travel burdens for rural patients, 2) reduce medical costs for patients and caregivers, and 3) increase patient
satisfaction without compromising quality of care. Despite these advantages, less than 1% of surgeons use
video visits. Research plan: This proposal directly responds to AHRQ’s Special Emphasis Notice which intends
to support career development grants (K08) focusing on health information technology implementation (NOT-
HS-13-011). It leverages mentors with expertise in health economics, implementation science, and telehealth
to generate an understanding of the role of monetary and non-monetary barriers on surgical video visit
adoption and how these barriers can be mitigated through interventions designed to drive behavior change.
This proposal has three research aims: 1) Evaluate the impact of payment reform on video visit use by surgical
patients; 2) Define non-monetary barriers to surgical video visit adoption; 3) Design and pilot an
implementation intervention to facilitate video visit adoption. Candidate: Dr. Ellimoottil is Assistant Professor of
Urology at the University of Michigan, where he completed a two-year health services research fellowship. Dr.
Ellimoottil has clinical, administrative, and research experience with telehealth through his virtual clinic, his
participation in Michigan Medicine's Virtual Care team, and his role leading a telehealth research collaboration.
Career development plan: Dr. Ellimoottil's career development plan builds upon his training and career
experience to: 1) To learn advanced quantitative methods (linked to Research Aim 1); 2) To learn survey
design and qualitative methods (linked to Research Aim 2), and 3) To learn principles of implementation
science relevant to telehealth adoption (linked to Research Aim 3). Mentorship team: Primary mentor Dr. David
Miller is a Chief Clinical Officer at Michigan Medicine. He is currently a principal investigator on an R01 grant
related to healthcare delivery reform. Co-mentor Dr. Sarah Krein has 20 years of experience in survey design,
qualitative methods, and implementation science. Co-mentor Dr. Andy Ryan is a health economist with
expertise in advanced quantitative methods, including econometrics. Dr. Ellimoottil’s advisory board includes
two nationally recognized telehealth experts (Drs. Rashid Bashshur and Judd Hollander) and an R01-funded
implementation science expert (Dr. Ted Skolarus). This study will benefit patients, practitioners, and
policymakers through the development of evidence-based methods to advance telehealth adoption. It will
produce the training, research experience, and preliminary data necessary for Dr. Ellimoottil to conduct an
effectiveness-implementation hybrid trial assessing the clinical and implementation outcomes from his
proposed implementation intervention. The overarching goal is to advance video visit adoption in order to
improve healthcare access, experience, and outcomes for patients undergoing surgical care.

Public health relevance
PROJECT NARRATIVE The proposed study seeks to define and overcome barriers to surgical video visit adoption. Improving avenues toward video adoption among surgeons will improve healthcare access, patient experience, and outcomes for millions of Americans undergoing surgical care, especially rural patients who travel long distances for care.